Protein dynamics from femtoseconds to milliseconds as crafted by natural and laboratory evolution: towards enzyme design

This R35 application describes our continuing and expanding program to develop and apply computational
methods to study how protein dynamics on many timescales contributes to enzymatic catalysis, and how some
enzymes are crafted by evolution to make use of protein dynamics on multiple timescales. This knowledge will
eventually inform approaches to design artificial enzymes – a grand challenge, as yet unmet.
Our studies of enzymatic catalysis began years ago with the first application of Transition Path Sampling
to chemical reaction in enzymes. The generation of reactive trajectory ensembles along with reaction
coordinate identification allowed us to postulate the concept of the protein promoting vibration: rapid protein
dynamics at or near the active site that are directly coupled to passage over the transition state barrier to
reaction. Such motions were found in multiple enzyme systems (but not all,) and their importance was verified
by experimental collaborators. More recently, application of these methods to artificial enzymes that are
subjected to optimization by laboratory evolution has shown the evolutionary process introduces such motion
into a static design and we have identified protein structural changes that allows the creation and coupling of
the dynamics. “Theozymes” created by de novo static structural methods have had limited success, while
laboratory evolution has allowed these proteins to develop significant catalytic power,
We will continue and significantly expand our program on this challenging topic through extensions of both
methodologies employed and with application to both natural and laboratory evolved enzyme families. In
addition to understanding how protein evolution leads to the coupling of rapid dynamics to barrier passage, we
will extend our approaches to be able to map how motions far more remote in time from the passage over the
chemical barrier can also be central to function. We will also develop methods that demonstrate how rapid
motions can prime the system for millisecond conformational change. Our goals for the program are to
understand how protein dynamics ranging from sub picosecond promoting vibrations to microsecond domain
motions to millisecond conformational motion are potentially inter-related and help form enzyme function, and
how such motions are orchestrated by the structure crafted by evolution.
The development of such tools coupled with studies of both laboratory and naturally evolved enzyme
families will allow the isolation of a “dynamics toolbox” employed by selection. We have already found how in
one laboratory evolved enzyme the introduction and loss of hydrogen bonds in strategic locations results in the
creation of a promoting vibration; successful completion of the proposed program will expand such
investigation to the full range of protein motion timescales appropriate to catalytic turnover, along with the
architectural changes needed to create such dynamics in the protein catalyst.

Public health relevance
Theoretical and computational methods are now central to understanding basic mechanisms in biological systems. Promoting vibrations in enzymes were discovered by our computational methods. We now propose to expand these studies to all timescales appropriate to enzyme turnover and eventually to the field of artificial enzyme design.